Pneumocystis: Macrophage & Epithelial Activation

ABSTRACT: Pneumocystis jirovecii pneumonia (PJP) remains a significant cause of morbidity and mortality in
AIDS1. During AIDS and other immunosuppressive states, the absence of CD4 lymphocytic immunity results in
serious PJP 2,3. In addition to CD4 cells, organism clearance requires a balanced macrophage response since
excessive inflammation promotes lung injury and respiratory failure4. We have shown that polarization of AMs
toward M1 versus M2 type phenotype, leads to detrimental lung inflammation during Pneumocystis
pneumonia5. Corticosteroids given in addition to antibiotics significantly improves outcome during PJP 6.
However, concerns exist that corticosteroids further suppress immunity and increase co-infections 7,8. New
strategies to promote killing and clearance of Pneumocystis while balancing lung inflammation are required for
patients with PJP, particularly for those who are refractory to antibiotic therapy alone. Our prior studies have
shown that host innate immunity to Pneumocystis is mediated by C-Type Lectin Receptors (CLRs) on
macrophages and involves downstream CARD9 activation 9. We have further shown that the CARD9 can be
targeted by a novel specific small molecule inhibitor (BRD5529) that significantly reduces inflammatory
signaling in macrophages stimulated with Pneumocystis 10. CARD9 serves as the central intracellular molecule
through which Dectin-1, Dectin-2, Mincle, and other CLRs signal 11. Dectin-1 CLR is activated through its own
intracytoplasmic ITAM domain12, while other innate CLRs (e.g. Dectin-2 and Mincle) require interactions with a
common Fc-gamma receptor (FcγR) accessory chain to mediate responses to Pneumocystis 13,14. Strikingly,
we observed that mice double deficient in both Dectin-1 and Fcer1g (which lack the FcγR gamma chain)
demonstrated markedly reduced organism clearance compared to Card9-/- infected animals. These mice also
possess deficiencies in immunoglobulin (Ig) Fc receptors directly mediating antibody uptake responses, further
implicating altered humoral responses in Pneumocystis opsonization and killing. Thus, we hypothesize that
innate immune responses through the CLR-CARD9 axis, humoral activity, and macrophage
polarization act together to mediate effective responses resulting in optimal organism uptake, killing
and generation of host inflammatory responses. This hypothesis will be addressed through three
independent but interrelated Aims. In Aim #1. We will determine the relative roles of CLRs, CARD9, and FcRγ-
mediated mechanisms in Pneumocystis organism clearance and inflammatory responses in vitro. We will
study alveolar macrophages (AMs) and bone marrow-derived myeloid cells from wild-type, CARD9, and
Dectin-1/FcRγ deficient animals. In addition, we will also now include mice deficient in all activating (FcγRI,
FcγRIII, and
FcγRIV, termed
FcγRI/
FcγRIII/FcγRIV-/- mice) Fc receptors but retaining the functioning FcRγ
chain signal transduction subunit. We will further study uptake and killing of Pneumocystis and subsequent
cytokine release after organism challenge with and without PCP convalescent serum. Additionally, we will
study polarization kinetics of AMs toward M1 or M2 type phenotypes after stimulation with Pneumocystis.
Under Aim #2, we will determine the relative roles of CLRs, CARD9 and antibody-mediated mechanisms in
Pneumocystis clearance and inflammation in mouse models of PCP. Studies will be performed in wild-type,
CARD9, Dectin-1/FcRγ, and FcγRI/FcγRIII/FcγRIV-deficient mice. We will evaluate Pneumocystis clearance
and inflammatory responses in both immune competent and CD4-depleted immunocompromised mice with
PCP. Strikingly, our preliminary studies show that while CD4-depleted Clec7a-/- Fcer1g-/- (Dectin-1/FcRγ
deficient) mice show significantly greater organism burdens compared to Card9-/- animals, and both deficient
mouse lines showed dramatic decreases in proinflammatory cytokines compared to wild-types, but similar to
one another. Accordingly, we will examine the kinetics of CARD9 driven innate immunity and the additional role
of antibody-mediated responses during PCP in both CD4-depleted and immunocompetent mice. Finally, in
Aim 3, we will exploit the differences in the CLR innate and antibody-mediated response pathways to test novel
therapeutic strategies for adjuvant treatment of refractory PCP. While current anti-PJP strategies are usually
beneficial, patients with severe refractory PCP (~30% cases) still experience high mortality (80%)15,16. We will
employ combinations of adjuvant antibody interventions to promote Pneumocystis clearance, along with
CARD9 inhibition strategies to blunt excessive inflammation during infection. These strategies will be
investigated in CD4-depleted mice, which mimic the immune deficiencies present during AIDS. Better
understanding of these responses and the ability to target them alone or in combination will be used to test
novel adjuvant treatment strategies in mouse models of severe PCP.

Public health relevance
PROJECT NARRATIVE: This proposal evaluates the role of Fcγ receptors not only in CARD9-CLR signaling but also in antibody-mediated uptake and killing of Pneumocystis by macrophages. Specifically, this proposal will evaluate the combined activities of both innate (CLR-CARD9 axis) and adaptive immunity components through their common reliance on the shared Fcγ receptors and how activation of host cells through these pathways provide additive benefits crucial for proper host immunity. We will further use these observations to develop novel therapeutic approaches targeting these pathways for PCP, for those who are refractory or fail standard antibiotic therapy.